SCH: Wireless sensing of biomarkers using intelligent surfaces for smart homes and sleep medicine

The ability to retrieve biomarkers like heart and respiratory rates without disrupting a user's typical sleep
environment can revolutionize sleep medicine, smart healthcare, independent living, and sleep health
monitoring of cancer patients. Sleep health is closely tied to cancer risk, cancer prognosis, and health-related
quality of life of cancer survivors. This need has driven an ever-growing interest in wireless remote sensing
of biomarkers using WiFi signals or radars to monitor cardio-respiratory signals and thereby assess sleep
quality, timing and duration. However, these technologies typically use a small number of antennas, limiting
their spatial resolution. As a result, their performance can drastically deteriorate when a user moves, changes
orientation, or when multiple people are present. This leaves wearable sensors as the main available non-
intrusive privacy-preserving technology for sleep monitoring, but they require frequent user intervention and
charging. To address these shortcomings, we will develop a smart wireless environment using multi-band
reconfigurable intelligent surfaces (RISs). These surfaces are low cost, low power, and can arbitrarily redirect
wireless signals. They are projected to play critical roles in next-generation wireless communication
networks, ensuring widespread deployment. Hence, the proposed system aligns synergistically with the
rollout of future wireless communication systems. By utilizing microwave RISs, we will retrieve users' low-
resolution RF reflectivity maps by developing a comprehensive physics-based model for RIS-based
computational imaging. This RF image is then interpreted using a novel multi-modal learning algorithm to
detect and track regions of interest (e.g., the torso). A high-resolution wideband millimeter RIS is then used
to focus on the user’s torso to retrieve breathing and heart rate with high spatial resolution. We will design
and experimentally verify the novel hardware and processing algorithms required to implement such a smart
wireless integrated monitoring (SWIM) system. We will demonstrate how multiple low-cost sensors in the
form of multiband, high-resolution intelligent surfaces and off-the-shelf radars can collaborate and robustly
retrieve critical cardiorespiratory biomarkers used to measure sleep without disrupting their daily routines.
RELEVANCE (See instructions):
The ability to monitor sleep by measuring breathing and heart rate using a smart system that uses wireless
waves from the walls of the rooms can revolutionize sleep monitoring in people with cancer. Poor sleep may
lead to cancer, and cancer treatment outcomes may be influenced by sleep including quality of life in
survivors. We will build and test a smart wireless system called SWIM to monitor sleep easily. Such an
approach will enable future sleep research for cancer prevention and treatment.